Improving the Detection, Classification and Treatment of Misaligned Arthritic Ankles

Ankle osteoarthritis (OA) is a debilitating and mobility limiting condition. It can commonly stem from
the result of a traumatic injury – such trauma has a high prevalence in military service. If cartilage is not
severely damaged in that trauma, the stability and alignment of the joint may be. Over time, an unstable or
misaligned ankle joint can experience abnormal rates of cartilage wear and tear due to aberrant kinematics.
While OA may take decades to develop, the resulting arthritic state from this trauma will ultimately require
ankle replacement or fusion, consequences with a tremendous financial burden and quality of life impact.
With regards to alignment, particularly in the coronal plane, current clinical diagnosis relies on static X-
ray of the ankle joint. Static images may not indicate dynamic misalignment during gait. Further, the effect of
wedged insoles, a potential conservative treatment, on the restoration of ankle function is undocumented.
This proposal aims to use biplane fluoroscopy, an X-ray based dynamic imaging approach, to measure
ankle kinematics in OA subjects (with varus, neutral and valgus ankle alignment) and controls. With this
method, tibio-talar kinematics during gait can be measured. Furthermore, subjects classified as neutral from
their static radiograph, but that exhibit ankle varus or valgus alignment during gait, will be identified.
Improving the accuracy of a diagnostic outcome provides a patient group with additional avenues for
treatment. We will investigate correlations between our 3D kinematics and clinical 2D imaging – to the benefit
of clinical diagnostics. We will also be able to measure the effect of wedged insoles on the restoration of ankle
function. With this in mind, the following aims and methodology are proposed.
Specific Aim 1: To investigate ankle kinematics in controls and subjects with OA. In
support of Specific Aim 1, 90 ankle OA subjects will be recruited (30 each of varus, neutral or valgus aligned
ankles). We will also recruit 20 control subjects. Subjects will receive CT scans of their feet to quantify bone
geometry (a step necessary for biplane fluoroscopy). Subjects will then be imaged in the biplane system during
gait trials and while wearing neutral study shoes. This will yield tibio-talar kinematics during gait for these
populations. Specific Aim 2: To identify dynamically misaligned ankles in OA subjects who are
currently classified as neutrally aligned using static analysis. We will compare the static X-ray and
the gait kinematics of OA subjects, particularly those with clinically determined neutral alignment. We will
determine what proportion of neutral OA subjects actually exhibit misalignment during gait and are thus
improperly categorized. We will also re-create 2D clinical X-ray views from our 3D data in an attempt to
translate our improvement (with 3D fluoroscopy) to more accurately classify alignment to clinical 2D
diagnostics. Specific Aim 3: To evaluate the potential of lateral or medial wedging to restore
alignment in misaligned ankle OA subjects. OA subjects will be imaged wearing shoes with wedged
insoles which correspond to their type of misalignment. Neutral OA subjects, who demonstrate misalignment
during gait, will be recalled for a wedged insole session. This yields conservative treatment kinematics.
This study will generate baseline data describing the kinematics of control and ankle OA subjects. This
data is not currently available in the literature, and represents a novel contribution to the field. Second, this
proposal determines how accurate current 2D X-ray methods are at detecting dynamic misalignment. This
information can inform clinicians about the accuracy of their diagnostic tools, and may lead to improvements.
Third, this proposal will generate data to evaluate the utility of wedged insoles for the conservative
management of ankle misalignment. In Summary, this study has immediate impact potential on the diagnosis
and treatment of ankle OA. Last, there are numerous additional avenues of classification, diagnostic, and
preventative research for the benefit of the veterans which will stem from this Career Development Award.

Public health relevance
The veteran population is prone to foot and ankle maladies from common injuries such as sprains, and diseases such as ankle osteoarthritis (cartilage damage). More specific to veterans are prior service injuries of the foot and ankle, which historically account for nearly a quarter of injuries received. These injuries include bone fractures and ligament damage. Some of these injuries may lead to poor ankle joint alignment, which over time could lead to osteoarthritis due to abnormal wear on a day to day basis. The goal of this proposal is to use a novel technology, biplane fluoroscopy, to study the movement of ankles which are misaligned in subjects with ankle osteoarthritis. This proposal will also benefit current diagnostic methods with additional information. Last, this proposal will test the effectiveness of a conservative treatment (modified shoe insoles) to correct or reduce the misalignment in ankles. This proposal will create evidence about: the nature of ankle osteoarthritis, the accuracy of diagnosing alignment, and conservative treatment for patients with ankle OA.